Research Core

The main goal of the Research Core (Core C) is to provide the requisite scientific leadership, infrastructure and monitoring support to carry out three thematically linked research projects: a prevention/intervention study and two stroke disparities studies. In addition, the Core C will act in a synergistic manner with the Research Education and Training Core (Core B) and the Administrative Core (Core A) in contributing to mentoring activities and review of research products. Core C is a partnership between the Research Division of the Hebrew Home at Riverdale (RD-HHAR) and New York University Center for Healthful Behavior Change housed at the NYU School of Medicine (NYUSOM). The Center for Stroke Disparities Solution is a consortium that includes NYUSOM, the RD-HHAR, Columbia University, the Visiting Nurse Service of New York and State University of New York-Downstate. The Specific Aims ofthe core are to: 1) Provide methodological consultation, data processing, management, and statistical support to three proposed research projects: Project I (Practice-based Trial of Home BP Telemonitoring Among Minority Stroke Survivors), Project II (Stroke Community Transition Intervention) and Project III (Tailored Approaches to Stroke Health Education); 2) In collaboration with Core B, provide support in research methods and biostatistics to selected junior investigators, and to investigators from underrepresented populations, and those interested health disparities; 3) In collaboration with Core A review research products (abstracts, manuscripts, and reviews) for dissemination; to foster collaborative research leading to the further growth of stroke disparities research; and to support ongoing projects and grant submissions.

Public health relevance
The Research Core provides the main scientific support for the mission of the Center, which is aimed at advancing innovative stroke disparities research and training the next generation of minority health disparities research investigators.